Targeting Lung Tissue Resident NK Cells with Inhaled IL-15 and TIGIT Blockade in Osteosarcoma

PROJECT SUMMARY
Cytokine immunotherapies, such as IL-2 and more recently IL-15, have been used to stimulate endogenous
cytotoxic natural killer (NK) and T cell responses against advanced cancers and to support adoptively transferred
lymphokine-activated killer cells. While responses have been achieved in some patients, the use of IL-2 and IL-
15 has been hampered by modest benefits with the risk of severe systemic toxicity, particularly when given
intravenously (IV). Distinct from IV delivery, inhaled IL-15 therapy offers the advantages of concentrated delivery
to the lungs, a frequent site of gross metastatic disease, while limiting systemic exposure and potential toxicity.
Osteosarcoma (OSA) is an aggressive primary bone cancer with a high propensity for lung metastases, and
outcomes for patients with lung metastases have been stagnant for the past 4 decades. In our recently completed
(manuscript in preparation) first-in-kind trial of inhaled rhIL-15 in dogs with spontaneous lung metastases from
OSA and melanoma, we observed clinical benefit in 37% (1 complete response, 1 partial response, and 5 stable
disease at 60 days in 19 dogs). Here, we propose to evaluate the immune mechanisms of response to inhaled
IL-15 in mouse and human models of metastatic OSA, hypothesizing that a unique tissue resident NK
population in the lungs has heightened cytotoxic and proliferative responses consistent with a memory-
like phenotype which enables augmented anti-tumor responses. In Aim 1, we will analyze lung resident NK
cells (CD3-NKp46+CD49a+) in K7M2 and LM8 models of OSA, hypothesizing that inhaled IL-15 delivered by
nebulizer will stimulate NK-mediated anti-tumor responses against OSA lung metastases. Matched human
blood, non-tumor-bearing lung, and tumor samples from patients with OSA undergoing metastasectomy will be
used to validate these mouse studies, in particular that human lung NK cells show features of heightened
cytotoxicity and effector function which can be harnessed to infiltrate immunosuppressive OSA metastases in
the setting on inhaled IL-15. In Aim 2, we will evaluate combination therapy. T-cell immunoreceptor with
immunoglobulin and immunoreceptor tyrosine-based inhibitory motif domains (TIGIT) has emerged as a critical
marker of NK cell exhaustion which limits anti-tumor responses in multiple cancer types, including sarcomas.
Thus, we will combine inhaled IL-15 with TIGIT blockade using anti-TIGIT monoclonal antibodies to assess NK
phenotype and function, trafficking to lung tumors, persistence, and tumor regression following treatment in
mouse models. Toxicity will also be carefully assessed given the potential for combination immunotherapy to
precipitate immunopathology and cytokine storm. Metastatic OSA is a rare and difficult-to-treat cancer. Despite
great success in other cancers, immunotherapy targeting PD-1, PD-L1, and CTLA-4 has shown minimal efficacy
in OSA, underscoring the need for novel immunotherapies for these aggressive cancers. This proposal will
evaluate novel strategies to stimulate tissue-resident NK cells in the lungs using inhaled IL-15 to maximize the
therapeutic exposure at the site of action while limiting systemic exposure and toxicity.

Public health relevance
PROJECT NARRATIVE Osteosarcoma (OSA) is a rare and difficult-to-treat cancer for which minimal improvements in systemic therapy have occurred over the last 40 years. In order to build on our exciting preliminary data that inhaled IL-15 has therapeutic efficacy in dogs with pulmonary metastases from naturally-occurring OSA, this proposal will evaluate the use of inhaled IL-15 (with and without TIGIT blockade) in murine models of OSA lung metastases as an innovative bedside-back-to-bench approach. We hypothesize that regional delivery of inhaled IL-15 will stimulate enhanced cytotoxicity and longevity in lung tissue-resident natural killer (NK) cells, thereby maximizing the anti- tumor effects of stimulatory immuno-cytokine at the site of action while limiting systemic exposure and toxicity.